International Brotherhood of Teamsters HAZMAT Training at DOE Nuclear Weapons Complex

Principal Investigator/Program Director (Last, First, Middle): Byrd, Lamont FOA Number RFA-ES-19-004
Program Summary/Abstract (DOEWTP)
Project Title: International Brotherhood of Teamsters HAZMAT Training at DOE
Nuclear Weapons Complex
Application Organization Name: International Brotherhood of Teamsters
Address: 25 Louisiana Avenue, NW Washington, DC 20001
Project Director Name: Lamont Byrd
Contact Phone Number: 202-624-6960
Email Address: [email]
Website: teamsterworkertrainingprogram.org
Grant Program Funds Requested: $6,028,025.90
The International Brotherhood of Teamsters (IBT) Consortium is applying for funding under the
DOE Worker Training Program (DOEWTP) cooperative agreement to provide appropriate model
health and safety training. The targeted population for the DOEWTP is workers who are engaged
in hazardous waste remediation, hazardous materials transportation, warehousing, and emergency
response on DOE sites.
The long term objectives and specific aims of the IBT Consortium are to increase worker,
community, and environmental safety and resilience by training workers to appropriately respond
to accidental releases of hazardous materials; work safely on hazardous waste remediation projects
on DOE sites; and safely transport hazardous materials, including radioactive materials, via truck
or rail.
The IBT Consortium will access the nationwide population of targeted workers through
established partnerships with appropriate local unions/lodges, community-based organizations, and
other partners to deliver training to 15,200 workers during the 5-year project period.
IBT Consortium Page 1 Program Summary/Abstract (DOEWTP)

Public health relevance
Principal Investigator/Program Director (Last, First, Middle): Byrd, Lamont FOA Number RFA-ES-19-004 Project Narrative (DOEWTP) The IBT Consortium represents and has ready access to thousands of workers throughout the DOE Nuclear Weapons Complex who remediate hazardous waste sites, transport hazardous wastes, handle, package, transport and warehouse hazardous materials, and respond to hazardous materials releases. The IBT Consortium is staffed by a team of highly experienced worker health and safety training experts who specialize in industrial hygiene, curriculum development, adult education techniques, information technology, and craft-experienced worker-trainers. The combination of access to worker populations and institutional capacities enables the IBT Consortium to deliver high quality model training that complies with the NIEHS Minimum Criteria, applicable standards and regulations as promulgated by the Department of Energy (DOE), Environmental Protection Agency (EPA), Occupational Safety and Health Administration (OSHA), and the Department of Homeland Security (DHS). IBT Consortium Page 1 Project Narrative (DOEWTP)